Core 2: Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
The Biostatistics and Bioinformatics Core (BBC), will facilitate translational research in prostate cancer, by
providing UCLA investigators and their colleagues with state of the art biostatistical, bioinformatics and clinical
trials support. The BBC provides a centralized network of biostatistics and bioinformatics support for prostate
cancer researchers at UCLA and their collaborators. The overall goal of the Core is to provide statistical and
bioinformatic support to basic and clinical investigators in the SPORE. The statistical consulting will be led by
Dr. David Elashoff and supported by Dr. Gang Li and will include consultation on power analyses and
experimental design for planning of preclinical and clinical studies. The core will collaborate on the development
of statistical analysis plans and assist with carrying out those plans. The Bioinformatics component will be led
by Dr. Thomas Graeber and supported by Dr. Paul Boutros. The Core provides analytical services for all
genomics research, including RNA/whole exome/T-cell receptor sequencing and proteomic analysis within the
SPORE. For these data types the core will assist with data preprocessing, pipeline development and cloud
computing, quality control evaluation, and both standard and custom integrative and network analysis. The core
will assist with the reporting of research findings in manuscripts. Finally, the Biostatistics and Bioinformatics Core
provides yearly educational seminars and courses to all SPORE investigators.

Public health relevance
NARRATIVE The Biostatistics and Bioinformatics core for the UCLA Prostate Cancer SPORE will ensure high quality research throughout the program by providing investigators with support in biostatistics and bioinformatics. This support will include the design of research projects, development of data analytic plans, carrying out statistical and bioinformatics analyses, and assisting with publication of scientific manuscripts based on the results of analyses.